Defining the microbiota's response to and influence on the evolution of Drosophila melanogaster

Understanding the mechanisms of fast adaptive evolution has direct applications to healthcare. But there
remains a major gap in the field: associated microorganisms (‘microbiota’), a key potential contributor to
animal adaptive evolution are often entirely ignored in evolution studies. The continued existence of this gap is
problematic because microbiota can directly affect host health-related traits. Indeed, many animal traits that
can evolve in response to laboratory selection can also be influenced by the microbiota. Moreover, when
populations undergo laboratory selection for divergence in health-related traits, they also become
differentiated in their microbiota. The long-term goal of this project is to define the role of microorganisms
in animal evolution. The overall objective is to explain how animals select on their microbiota during
evolution and how variation or constancy in the microbiota affects animal evolution. Our central hypothesis
is that microbiota affect and are affected by animal evolution. This hypothesis is supported by our preliminary
results using a system of experimentally-evolved Drosophila melanogaster (laboratory fruit fly) populations.
Thus, the rationale for the proposed project is that we have a demonstrably high-powered and unique system
in which we can answer questions about causation when determining the role of microbiota in host evolution.
We will achieve our overall objective through two specific aims. Preliminary results show that populations of
D. melanogaster selected for fast development have higher abundance of gut microbes but are nearly devoid of
the endosymbiont Wolbachia compared to controls; in Aim 1.1 we hypothesize that host genetic control of
Wolbachia is under strong and constant selection in these populations. In Aim 1.2 we will determine whether
the evolution in host traits drives the changes to the microbiota, or vice versa in a laboratory selection
experiment. Aims 2.1 and 2.2 will also use the laboratory selection approach to test if bacterial functions can
affect selection pressures acting on hosts, and to what extent variation or constancy of the microbiota affect
host rate of evolution. Our approach is innovative because it evolves an animal under bacteria-controlled
conditions and extends correlation to causation. The significance of this project is that it will explain how
host evolution impacts and depends on the microbiota and determine to what extent microbiota can influence
selection pressures experienced by hosts. This project will support research opportunities for undergraduate
and Master’s students.

Public health relevance
Animals, including humans, have dense and diverse communities of microbes living in and on their bodies (‘microbiota’) that influence health-relevant traits. Less is known about how the health influences of the microbiota are related to animal evolution. This work will provide explanations for how animals select on their microbiota during evolution and how variation or constancy in the microbiota affects animal evolution, as steps towards defining the role of microorganisms in evolution.